Ketamine-assisted integrative treatment for Veterans with chronic low back pain and comorbid depression

Background: Chronic low back pain (CLBP) and depression are the two most common causes of disability in
America. When they occur together, patients have more functional limitations, higher healthcare spending, and
treatment is more likely to fail. Ideal treatments would address pain interference with function and improve
mood in patients with both CLBP and depression. Ketamine is an anesthetic with rapid analgesic and
antidepressant properties. Unfortunately, its effect for both pain and depression fades over time, necessitating
maintenance dosing. Thus, non-invasive treatments that enhance and sustain its benefits are needed.
Significance/Impact: This application proposes a career training and research plan to develop a narrative
intervention designed to be administered shortly after a series of ketamine infusions, conduct initial pilot
testing, and complete a small feasibility randomized controlled trial (RCT). A narrative intervention, [designed
to be delivered in the days after receiving ketamine,] could be particularly helpful [in reducing pain
interference] for patients in whom formal psychotherapy may not be acceptable. Narrative interventions reduce
distress by helping people organize difficult experiences (such as chronic illness) into a cohesive story; this
process results in the perception that the experience is more manageable. Commonly used in palliative care,
narrative interventions have demonstrated effectiveness for both pain and depression and are highly
acceptable. This research agenda is well-aligned with the Clinical Science Research and Development priority
research focus on both chronic pain treatment alternatives to opioids and mental health conditions highly
prevalent in Veterans (e.g., depression). Short-term, results will lead to a Merit Review proposal to test the
intervention in an adequately powered RCT. Long-term, Dr. Powell will gain skills broadly applicable to (a)
complex intervention development (e.g., those combining pharmacologic and behavioral components) and (b)
designing and conducting high quality clinical trials of these treatments in Veterans with chronic illnesses. Dr.
Powell is a VHA palliative care physician and research scientist whose long-term goal is to become an
independent investigator focused on improving outcomes for Veterans with chronic pain and psychosocial
distress.
Innovation: This study will be the first to test a narrative intervention as a strategy for enhancing ketamine’s
benefits, with an emphasis on pain interference with function. It focuses on Veterans with both CLBP and
depression – a population that stands to benefit from ketamine’s analgesic and antidepressant actions.
Specific Aims: Study Phase I aims to develop and refine a targeted narrative intervention for Veterans with
CLBP and co-occurring depression using a modified ADAPT-ITT approach. The initial aim involves the
identification of relevant components of existing narrative interventions followed by semi-structured
interviews with Veterans and clinicians to obtain detailed feedback. Next, an open-label pilot involving a series
of ketamine infusions followed by the narrative intervention will assess initial feasibility and barriers, allowing
protocol refinement. Study Phase II will consist of a 2-arm pilot RCT with a control group who does not receive
the narrative intervention [(n=22 participants/group)].
Deliverables from Aims: Two manuscripts per aim are anticipated. Importantly, this work will facilitate sample
size calculations to inform an adequately powered RCT to be submitted as a Merit proposal (Year 4). This RCT
will investigate the impact of the intervention upon the primary outcome - pain interference with function. Dr.
Powell will work with her mentorship team to disseminate findings and strategically implement this work to
maximize benefits for Veterans.

Public health relevance
One-third of all Veterans have chronic low back pain (CLBP), and Veterans with CLBP are twice as likely to have co-occurring depression. Compared with the general population, Veterans are both more likely to have CLBP and their pain is more likely to be severe. Even though the proportion of Veterans with medical comorbidities such as diabetes or heart disease is stable or decreasing over time, chronic pain and depression are both increasing. Unfortunately, many Veterans with CLBP (especially those with comorbid depression) experience little to no functional improvement with current treatments. We propose to address this gap by developing an effective and acceptable treatment for Veterans with CLBP and comorbid depression. We will obtain extensive Veteran input during each phase of the project (development, pilot testing, and initial efficacy testing). This work will inform a high-quality clinical trial, thus aligning with the VA Office of Research and Development’s Strategic Research Priority of improving Veterans’ access to high-quality clinical trials.